EEG Signature Analysis for Drug Repurposing for Rare Diseases

PROJECT SUMMARY
The high rate of failure in CNS drug discovery, in particular of the first-in-class therapeutics with new modes of
action, highlights a clear unmet need to improve the success rate in drug discovery for rare diseases and
psychiatric disorders. One well-known issue is the high cost, high risk, and low development time for drug
development, time, and costs that most of the 10,000 rare disorder patients and support organizations cannot
afford to support or wait for. Another important issue is the lack of clear targets for many for most rare diseases,
which are complex and may require polypharmacology. Phenotypic screening platforms are well-suited for drug
repurposing of drug in a target-agnostic manner. Suitable proven in vivo phenotypic screens, however, are
scarce with the exception of PsychoGenics SmartCube® platform, which has been developed in the past few
years for drug repurposing approaches using behavioral data, combining reference drugs’ signatures, and
comparing them against disease animal models’ signatures. Our aim for this Fast Track project is to create a
similar repurposing platform based on EEG data, using our eCube® fast EEG platform. To do this we will assess
in eCube® several animal models of rare disease to create a small database, increase our reference drug EEG
database, and use a novel algorithm, called Drug EEG Signature Analysis (DESA) to compare the two datasets
and generate at once a multitude of hypotheses for potential drug repurposing. These hypotheses to be
evaluated empirically using such models of disease. If our Phase I proof of concept project is successful, we will
use the Phase II period to get the platform ready for commercialization. If successful, this platform will be an
innovative and unique drug repurposing platform, offered as fee-for-service or used in drug development by PGI
and its partners.

Public health relevance
PROJECT NARRATIVE There is a great unmet need to repurpose already approved drugs for rare disorders as success rate in drug discovery has a high rate of failure, is costly and a slow process. In addition, drug companies may not have good incentive to take such a risky approach to drug development for the 90% of rare diseases that have no approved therapeutic treatment. Given the need to address repurposing in an efficient and systematic manner, PsychoGenics Inc. will develop a novel machine learning-based statistical approach to drug repurposing that can identify compounds and predict their phenotypic therapeutic potential for a portfolio of different rare disorders (at once) to guide the early stages of drug validation and translation to the clinic.